Novel compression strategies for efficient storage, retrieval and analysis of sequence data

Project Summary/Abstract
A post-genomic era is upon us, marked by the rapid availability of massive sequence data. Storing,
retrieving, and analyzing such high volumes of raw sequence data, as well as alignment information, pose
signiﬁcant challenges to researchers in the ﬁeld. Consequently, new methods are desirable to support
efﬁcient storage and retrieval of such data to meet the demand of the exponential growth in sequence data.
Within this scope, we will develop a suite of novel computational methods for compressing sequence data.
Our proposed research includes three speciﬁc aims to develop: (1) an error-bounded lossy compressor
for quality scores in sequence ﬁles, (2) an adaptive compression strategy to achieve optimal performance,
and (3) a high-throughput compression framework for efﬁcient sequence compression. We will extensively
evaluate the proposed approaches on real and synthetic datasets, and develop modularized software tools
to facilitate the application of the proposed methods. With a well-deﬁned research plan for developing
innovative methodologies to compress sequence data, this project will establish a new paradigm of data
compression to support efﬁcient storage, retrieval, transfer, and analysis of the ever-growing DNA and RNA
sequencing data.

Public health relevance
Narrative We will develop novel analytics to compress large-scale sequence data quickly accumulated in the community. This work is relevant to public health and the mission of the NIH since this project will provide new development and applications of computational tools to facilitate basic research and clinical practices. The proposed research will provide a new generation of software modules and packages for sequence data compression, that will be readily applicable to many investigations in precision medicine and public health.